CORE--TISSUE CULTURE

The Tissue Culture core component will provide two essential services to the program. Organizing these services within a core will be beneficial for both cost-saving and quality-control. the specific aims are: 1. To store, maintain and provide to the investigators various cultured cell lines on a regular basis. 2. To purchase, store, perform quality controls and provide to the investigators tissue culture media, serum and antibiotics.